Routes to enhanced HIV neuropathogenesis through expression of subclinical levels of endogenous amyloid-beta

This is a resubmission of a collaborative project between HIV and Alzheimer’s Disease (AD) laboratories to
investigate potential synergy between HIV infection and amyloid β (Aβ), a hallmark of AD, in promoting memory
impairment. Half of HIV patients on antiretroviral therapy develop neurocognitive impairments (NCI) despite low
HIV brain burdens. Age is the most consistent factor affecting NCI progression. We reproduced HIV-NCI
pathogenesis in conventional mice infected with EcoHIV, a mouse-tropic HIV. The Project MPI, Dr. Arancio,
reported that non-synaptotoxic doses of exogenous oligomeric Aβ (oAβ) and Tau, another AD hallmark,
cooperate in synaptic dysfunction and memory impairment in mice, suggesting that AD proteins have pathogenic
potential at their subclinical concentrations. Our revised preliminary results show such cooperation between
EcoHIV and oAβ in multiple formats including after EcoHIV infection of AD mouse models prior to their cognitive
decline. The models included transgenic APP/PS1 mouse model of familial AD (FAD) and two late onset AD
(LOAD) mouse models expressing humanized AD proteins. We propose that HIV and subclinical oAβ processes
cooperate in disrupting synaptic plasticity to exacerbate HIV-NCI beyond each agent alone. The Specific Aims
are to: 1) Characterize enhanced HIV-NCI pathogenesis in FAD and LOAD mouse models prior to onset of their
AD symptoms. (A) optimize the onset of memory deficits with EcoHIV infection in preclinical APP/PS1 mice; (B)
determine HIV-NCI severity at disease onset by infected APP/PS1 mice by hippocampal LTP, synaptodendritic
injury, apoptosis, APP processing, and amyloid pathology (C) Conduct similar studies by EcoHIV infection of
LOAD model mice expressing various humanized AD genes and select one LOAD model for further studies 2)
Using APP/PS1 mice and one LOAD strain, conduct next generation RNA sequencing (RNA-seq) in EcoHIV
infected mice upon reaching HIV disease state (A) generate transcriptome from hippocampus (HPC), prefrontal
cortex (PFC), and striatum (STR), and define biological processes specifically associated with memory defects
caused jointly by HIV and oAβ; B) confirm some gene modulation by RT-QPCR in HPC and STR extracts or by
immunostaining in brain section; and C) conduct limited nuclear-RNA-seq analysis in HPC to assign altered HIV-
oAβ processes/transcripts to specific cell types. 3) Study molecular mechanisms responsible for promoting HIV-
NCI pathogenesis in the setting of naturally produced subclinical levels of human oAβ in mice. (A) since both
HIV and Aβ disturb wnt signaling and cause dendritic pruning, examine how HIV infection of myeloid cells works
with Aβ in dysregulating Wnt function in dendritic integrity. B) since EcoHIV downmodulates CaMKII and CREB
in mice study potential Aβ-HIV convergence in oAβ dysregulation of the CREB role in synaptic strengthening.
Studies will include EcoHIV infection of moderate and late onset AD mice, tests of learning and memory, HPC
long-term potentiation, HPC synaptodendritic integrity, apoptosis, APP processing, and amyloid pathology
system and brain HIV burdens, bioinformatics of mouse brain and select cell types.

Public health relevance
Despite effective antiretroviral therapy, half of HIV infected people develop problems in learning and memory that worsen with age sharing some features with aging and age- related neurodegenerative disease, Alzheimer's disease (AD). To determine how these aging conditions may affect each other and accelerate disease development, this project employs mouse models that bring together elements of each disease before mice suffer learning disability. To determine the relevant factors, brains from affected mice will be tested to reveal common or interacting paths of gene expression dysregulation, with the long-term goal of identifying new targets for treatment to arrest HIV-associated cognitive disease before it progresses irreversibly with age.